Role of endogenous opioids in respiratory development

PROJECT SUMMARY
This K99/R00 Pathway to Independence Award is designed to allow me to achieve my long-term goal to
establish an independent research career focused on respiratory circuit and breathing development. Newborn
breathing conditions are common and can result in slow, irregular breathing which can be life-threatening.
Understanding how neuromodulators, such as endogenous opioids, influence respiratory neuron and breathing
development may reveal novel strategies for improving breathing during early life. Administering the opioid
receptor antagonist naloxone has been shown to stimulate breathing in newborns but earlier studies may have
missed a longer-acting role of endogenous opioids in respiratory neuron maturation. It is unknown if
endogenous opioids influence the postnatal development of respiratory neurons and breathing. The overall
hypothesis of this research is that endogenous opioids influence breathing and respiratory neuron
development in a cell-type specific and developmental time point specific manner. To test this, I propose the
following specific aims: Aim 1. Determine how endogenous opioids influence the physiology and morphology of
developing brainstem respiratory neurons. Aim 2. Determine how mu opioid receptors and endogenous opioid
peptides influence breathing during development. To accomplish these aims, I will use mice with whole-body
deletion of mu-opioid receptors and the opioid peptide enkephalin. Brain slice electrophysiology and
immunohistochemistry will be used to understand how altering endogenous opioids impacts the physiology and
morphology of respiratory neurons, respectively (Aims 1a,b). I will evaluate breathing in awake mice with
whole-body deletion of mu opioid receptors or enkephalin over a developmental time course (Aim 2a). I will
also measure breathing in mice with medulla- and pons-targeted deletion of mu opioid receptors or enkephalin
(Aim 2b). Finally, I will determine the timing and location of endogenous opioid release using a genetically-
encoded opioid sensor in brainstem tissue from mice at different developmental time points (Aim 2c). I will
receive training in brain slice electrophysiology in neonatal mice, opioid pharmacology, in vivo breathing
measurements, advanced live confocal imaging, and in utero microinjection to express a genetically-encoded
opioid sensor in brainstem neurons in mouse embryos. This research will determine the fundamental role of
endogenous opioids in respiratory neuron maturation and breathing development. I will complete my research
and career training plan under the mentorship of Drs. Erica Levitt and Lori Isom, as well as my mentoring team
comprised of experts in the proposed techniques. Together, the proposed research and career training will help
me achieve my long-term career goal of being an independent investigator studying the mechanisms of
newborn breathing conditions.

Public health relevance
PROJECT NARRATIVE Newborn breathing conditions can occur when respiratory neurons fail to develop properly. Respiratory neurons express mu opioid receptors during development and endogenous opioids, such as enkephalin, are thought to influence their activity since blocking opioid receptors stimulates breathing near birth. This research will determine the fundamental mechanisms by which mu opioid receptors and enkephalin influence respiratory neuron maturation and breathing development.